Investigating the role of helix-1 in the fibrillization of SAA1-76

PROJECT SUMMARY/ABSTRACT
AA amyloidosis is a severe complication of chronic inflammatory disorders and is potentially fatal. The
amyloid fibrils involved in AA amyloidosis are derived from serum amyloid A (SAA), which is an acute phase
reactant protein. In AA amyloidosis, circulating amyloid fibrils are deposited in organs, ultimately leading to their
failure. Serum amyloid A (SAA) is the major protein component of amyloid fibrils associated with AA amyloidosis.
There is accruing evidence that overexpression of SAA is correlated with the severity of inflammation caused by
COVID-19. These highlight the need to unravel the mechanism of SAA misfolding that could in turn facilitate the
design of potential inhibitors. Molecular dynamic (MD) simulations have yielded an in silico model for SAA
misfolding where the N-terminal helical (helix-1) region plays a pivotal role. Helix-1 is believed to transition from
a -helix to -hairpin. Once formed, the -hairpin units are postulated to associate and stack upon themselves
to yield fibrils. We propose to investigate the veracity of the in silico model of SAA misfolding by synthesizing
and characterizing peptide mutants derived from the helix-1 region of SAA and the longer fragment, SAA1-76. The
roles of specific amino acids will be probed along with the trajectory each takes during SAA misfolding. Using
standard spectroscopic methods, we will determine changes in amyloidogenic propensity, conformation, key
molecular interaction, and amyloid morphology of each peptide during or after SAA fibrillization. Experimental
data will be correlated with the findings of the in silico results to yield information on the mechanism. The data
obtained from helix-1 fragments SAA1-13 and SAA1-27 will be extended to the truncated peptide, SAA1-76, found in
amyloid deposits of SAA. We intend to emply in silico and in vitro study to help yield important mechanistic clues.
One of the major goals of this project is to provide students, >50% of whom are underrepresented minorities,
with the opportunity to conduct research and gain experience working in a modern biomedical laboratory.
Undergraduate researchers involved in the project will be expected to synthesize and spectroscopically
characterize peptides, verify spectroscopic data using MD simulation, and characterize amyloid morphology.
Each student will focus on aspects of the project that best interest them and fit their background. Regular
research group meetings will ensure that students participate in the planning of experiments and analysis of
data. Students will have the opportunity to apply theories learned in the classroom to real world biochemical
investigation. Research experiences that are based on current technology allow students to solidify and fortify
their knowledge. Hands-on experiential learning is one of the most effective approaches to develop students’
critical thinking, perseverance, and confidence that could translate to a fulfilling career. Their experience will help
them enter graduate programs and/or find employment in biomedical careers. The educational impact of this
project also extends to local high school and community college students working in the PI’s laboratory. The
research experiences of these students will help ensure the vibrancy of the scientific infrastructure in the US.

Public health relevance
PROJECT NARRATIVE Aggregation of serum amyloid A (SAA) and the formation of circulating amyloid fibrils is pivotal to the development of SAA amyloidosis which is a potentially life-threatening complication of chronic inflammatory diseases. The focus of this proposal is to experimentally determine the mechanism of SAA misfolding and compare it to recent theoretical models. A better understanding of the mechanism of SAA aggregation will lay the foundation for the development of potential therapeutic agents.